Identifying the targets of protective immunity to severe falciparum malaria

ABSTRACT
The goal of this R01 application is to discover the targets of naturally acquired protection against severe
Plasmodium falciparum malaria and to develop them as novel blood-stage vaccine candidates. Of the ~100
malaria vaccine candidates currently under investigation, more than 60% are based on only four parasite
antigens and the most advanced vaccine, RTS,S, generates only modest protection 1, 2.
In previous studies, we developed a highly innovative whole proteome differential screening strategy which
identifies the subset of parasite antigens that are recognized by antibodies expressed by resistant individuals
but not susceptible individuals. Using this strategy, we discovered Schizont Egress Antigen-1 (PfSEA-1), a
244-kDa parasite antigen that is the target of antibodies which arrest parasites at the schizont stage and are
associated with significant protection from severe malarial disease in a cohort of n=785 two yr old children.
This is the first demonstration that antibodies that specifically block egress can protect against severe malaria
in humans (Science 4).
In parallel studies, we also identified PfGARP, a previously unrecognized vaccine candidate which localized
to the exofacial surface of the RBC membrane in trophozoite infected RBC. Antibodies to the highly invariant
carboxyl terminal of PfGARP (PfGARP-A, aa 411-673) inhibit parasite growth in vitro by 99% compared to
controls (P < 0.001) by killing trophozoite stage parasites. Numerous mechanistic assays demonstrated that
the binding of anti-PfGARP to the surface of the infected RBC induces parasite programed cell death as
evidenced by pyknotic nuclear morphology, caspase activation, mitochondrial depolarization, DNA
fragmentation, and release of intracellular calcium. In addition, vaccination of non-human primates with
PfGARP formulated as a lipid encapsulated mRNA results in significant protection from P. falciparum challenge
compared to controls (Nature 5).
These preliminary results were based on differential screening using sera from resistant and susceptible
individuals with the definition of resistance based solely on parasitemia. Previous work has demonstrated that
children develop resistance to severe malaria after only one or two episodes, and this protection is distinct from
responses that simply control parasitemia 6. In the current proposal, we will capitalize on this observation to
identify parasite antigens that are targets of antibody responses which are acquired and expressed during the
convalescent phase of an episode of severe malaria and protect against future episodes of severe malaria.
We will: 1) conduct a case-control study at our field site in a holoendemic region of western Kenya to
identify infants and children with severe malaria and matched controls. 2) perform whole proteome differential
screening using sera from this case-control study, and 3) down select candidates for follow-on vaccine studies
using a suite of assays (growth inhibition, human immunoepidemiologic studies, and murine vaccine trials).

Public health relevance
NARRATIVE The goal of this R01 application is to discover the targets of naturally acquired protection against severe Plasmodium falciparum malaria and to develop them as novel blood-stage vaccine candidates. We will: 1) conduct a case-control study at our field site in a holoendemic region of western Kenya to identify infants and children with severe malaria and matched controls. 2) perform whole proteome differential screening using sera from this case-control study, and 3) down select these candidates using a suite of assays (growth inhibition, human immunoepidemiologic studies, and murine vaccine trials).